Administrative Core

Summary
This Administrative Core fosters our coalition of clinicians and scientists across the six institutions of our
Coccidioidomycosis Collaborative Research Center (CCRC) and aligns our activities to the priorities established
by the NIH for this program. To manage our activities, we propose this Administrative Core to interface with each
Core and Project and with NIAID/NIH Program Officers. This core will be directed by the UCLA MPI (Butte) and
the UCSD MPI (Hoffman), and managed by Alexis Stephens, Clinical Research Coordinator, UCLA Division of
Immunology. The administrative duties of this core include management of resources, implementation of policies
and best practices, arranging the timely flow of clinical samples, coordination of communications and
publications, and storage and sharing of data. The overall goals are to maximize the productive research
potential of all Projects and Cores, and ensure the timely completion of goals of this program.
In Aim 1, we provide infrastructure support to ensure completion of all research objectives. We will Develop
a management plan (leadership and staff), develop an organizational structure and regular meetings, including
monthly, quarterly, and Annual Meetings. We will also establish an External Advisory Board in consultation with
the NIAID. We will establish a conflict resolution system. We will ensure regulatory compliance and maintain
records for all Projects and Cores. An innovative part of this proposal is the development of a LabKey database
to track all clinical phenotypes, genomics, and results. Finally, we will ensure close involvement with NIAID.
In Aim 2, we provide support for fiscal management and reporting. The Administrative Core will coordinate
Principal Investigators and Key Personnel and will organize communications, group meetings, teleconferences,
and publications. The Administrative Core will track funds and expenses across all sites
In Aim 3, we Establish the Development Research Program, including its administration and the mentoring
roles.